New Proximity Labeling Tools for Studying 3D Chromatin Structure and Function

PROJECT SUMMARY The highly-organized packing of eukaryotic genetic material as chromatin fibers in three-
dimensional space is critical for proper gene expression and genome maintenance. Of note are topologically-
associated domains (TADs) containing neighborhoods of insulated chromatin loop regions bound by clustered
cohesin and CCCTC-binding factor (CTCF) homodimers. The integrity and maintenance of these insulated
neighborhoods are important as disruptions to loop structure can result in gene misregulation and proto-
oncogene activation. However, current biochemical tools are insufficiently developed to study questions
concerning the mechanism of neighborhood formation, regulation and dynamics. Thus, we need molecular tools
that enable real-time, high-resolution analysis with minimal pertubation on cellular function.
This proposal will combine molecular biology tools with the knowledge of photochemistry to develop
an optogenetic tool for labeling the molecular interactome within live cells. A genetically-encodable
photocatalytic protein (SOPP) is used to generate reactive intermediates from a biotin-appended probe that in
turn, covalently tag biomolecular interactions within radial distance of protein localization. Preliminary
experiments nuclear proteins can be labeled with high temporal specificity using short irradiation times. I
anticipate that this method will be applied towards mapping the protein interactomes of other organelles, using
quantitative proteomic data as further confirmation of this method. Conditional systems for proximity labeling
using split-SOPP (sSOPP) will be developed for proximity-gated microenvironment mapping. Finally, SOPP-
activatable chemical probes with different reactivities and radial labeling radius will be synthesized and validated.
Using this new optogenetic proximity labeling tool, the three-dimensional architecture of chromatin will be
mapped using nuclease dead Cas9 (dCas9)-SOPP fusions guided to genomic sites using defined signal guide
RNAs (sgRNAs). SOPP-CTCF and SOPP-cohesin fusions will be used to map multisite interactions. This
approach should provide insight into the dynamics of factors that engage genes within insulated regions.
Additionally, using the sSOPP approach for proximity-gated CTCF-cohesin labeling will provide a more accurate
picture of loop region interactomics. Lastly, the dCas9-SOPP technology will be used to study the differences in
the interactome of intact and disrupted proto-oncogene containing loops, especially with regard to the factors
involved in gene regulation. As a more holistic approach to mapping molecular interatomics, an orthogonal
nucleic acid labeling method will be adapted to this workflow to create a multiplexed system capable of mapping
both protein and nucleic acid chromatin neighborhood loop interactomes in live cells.
Successful completion of the proposed research will provide a new optogenetic tool that will be used
by the broader epigenetics community to understand the causative impacts of higher-order
chromosomal architecture on gene regulation, and their role in cancer development and progression.

Public health relevance
PROJECT NARRATIVE Deciphering the interplay of transcriptional enhancers and gene expression within three-dimensional chromatin architecture is a fundamental challenge in molecular biology, and to answer these questions, minimally-pertubative, localizable tools that enable real-time, high-resolution analysis are needed. The proposed research details a genetically-encodable, photo-controllable tool that can be used to map the molecular interactome of three-dimensional chromatin structures within live cells with high spatiotemporal resolution. Successful completion of the proposed research will uncover causative impacts of higher-order chromosomal architecture on gene regulation, and their role in cancer development and progression.